COAGULATION ACTIVATION IN SICKLE CELL DISEASE

As a result of the presence of macrovascular thrombotic complications, as well as the biochemical evidence of ongoing coagulation activation, sickle cell disease (SeD) is often referred to as a hypercoagulable state. However, the contribution of coagulation activation to the pathogenesis of SCD remains uncertain. While the majority of clinical studies using anticoagulants have shown no convincing benefit in the prevention or treatment of acute pain episodes, most of these studies were small and poorly controlled. Furthermore, because the acute pain episode appears to result from the occlusion of postcapillary venules by the interaction of red blood cells and other cellular elements with the vascular endothelium and subendothelial matrix proteins, it may not be the ideal clinical endpoint for assessing the effect of anticoagulation in SeD patients. Pulmonary hypertension (PHT), a common complication associated with significant morbidity and mortality, and with histopathologic find ings of in situ thrombosis involving pulmonary vessels, represents a clinical endpoint that is likely due, at least in part, to increased thrombin generation, and may therefore be used to evaluate the contribution of coagulation activation to the pathophysiology of SCD. The UNC Comprehensive Sickle Cell Program offers a large and closely followed patient population in whom we will be able to study in detail the contribution of hypercoagulability to the pathophysiology of SCD-associated PHT. Our expertise in the care of patients with SCD, as well as ongoing research interests in hemostasis and thrombosis, makes our center an ideal one to answer this fundamental question. We hypothesize that increased thrombin generation, as well as platelet activation are central to the pathophysiology of SCD and contribute to the occurrence of several SCDrelated complications, including PHI. As a consequence, treatment modalities that down-regulate thrombin generation would be expected to delay the progression of PHT and result in improved survival in patients with SCD. The long-term goals of our proposed work are to: 1) evaluate the safety and efficacy of anticoagulation in SCD-associated PHT;and 2) evaluate the effect of anticoagulation on plasma markers of thrombin generation, platelet activation, as well as endothelial activation in SCD patients with PHI.

Public health relevance
The contribution of coagulation activation to the pathophysiology of sickle cell disease (SCD) remains uncertain. However, patients with certain SCD-related complications such as pulmonary hypertension are known to exhibit evidence of a thrombotic arteriopathy involving their pulmonary vessels. Furthermore, these patients manifest evidence of increased plasma markers of thrombin generation compared to patients without pulmonary hypertension. In this application, we will explore the contribution of coagulation activation to the pathophysiology of SCD by addressing the following specific aims: We have proposed a clinical study of the anticoagulant, warfarin, to evaluate it efficacy and safety in SCD patients with mild pulmonary hypertension. In addition, we will evaluate the effect of anticoagulation on plasma markers of thrombin generation, platelet activation, endothelial activation and mortality in SCD patients with mild pulmonary hypertension.